Cancer Center Support Grant

RESEARCH PLAN – RUTGERS CANCER INSTITUTE OF NEW JERSEY OVERALL
PROJECT SUMMARY/ABSTRACT
The Rutgers Cancer Institute of New Jersey (CINJ) is a matrix/consortium (with Princeton University [PU]) and
is New Jersey’s only NCI-designated Comprehensive Cancer Center, serving a diverse population of 9.2 million.
CINJ focused the strengths and resources of the major research institutions in NJ on addressing the cancer
burden in its catchment area (NJ). CINJ is an independent institute of Rutgers University (RU), optimizing its
potential for growth and transdisciplinary collaboration (multi-PI grants increased 110%). In FY2023, CINJ
received over $140 million of institutional support (RU and PU, the State of NJ, the RWJBarnabas Health System
(RWJBH), philanthropy). The table below illustrates a few metrics of CINJ’s success in this grant period.
Metric 2018 2022 Increase
Center Members 165 (19 PU) 275 (28 PU) 67%
Ca Focused Peer Reviewed Support $45M ($5.4M PU) $55M ($8M PU) 22%
NCI Institutional Training Grants 0 4 N/A
Space (*at onset of new grant period) 317K sf 1.1M sf* 247%
Patient Visits 67,011 189,681 183%
Interventional Therapeutic Trial Accrual 311 600 93%
State Support $31M $53M 71%
Counties Covered by ScreenNJ 3 21 (all) 600%
Steven K. Libutti remains CINJ
Director, Vice Chancellor for
Cancer Programs for Rutgers
Biomedical and Health
Sciences, and RWJBH Senior
Vice President for Oncology
Services since 2017. CINJ
entered into an innovative
Integrated Practice Agreement
with RWJBH that provides a financially sustainable model for provision of high-quality, cutting-edge, academic
oncology services, and enabled system-wide restructuring of the clinical trial enterprise and a significant increase
in accruals. Driven by its Strategic Plan, CINJ increased high impact center science; supported a plan to enhance
diversity; and increased the impact of the Community Outreach and Engagement Office on its catchment area.
CINJ’s Research Programs all demonstrated enhanced collaborations and scientific impact: 1) Cancer
Metabolism and Immunology, 2) Genomic Instability and Cancer Genetics, 3) Cancer Pharmacology, 4) Clinical
Investigations and Precision Therapeutics, and 5) Cancer Prevention and Control. The Programs are supported
by shared resources (Biomedical Informatics, Biostatistics, Biorepository and Histopathology, Genome Editing,
Comprehensive Genomics, Immune Monitoring/Flow Cytometry, Metabolomics and Cancer Prevention/
Outcomes Data Support) and other services. CINJ’s future is guided by a Strategic Plan that includes increasing
access for NJ residents to screening (new ScreenNJ mobile unit); increasing trial accruals through an expanded
clinical research infrastructure; improving representation of URM faculty and staff in leadership; increasing multi-
project grants through strategic investment; and operationalizing the Jack and Sheryl Morris Cancer Center, NJ’s
only free-standing cancer hospital. We are requesting re-designation as an NCI Comprehensive Cancer Center.

Public health relevance
RUTGERS CANCER INSTITUTE OF NEW JERSEY PUBLIC HEALTH RELEVANCE STATEMENT The catchment area of Rutgers Cancer Institute of New Jersey (CINJ) is the state of New Jersey (NJ), with a diverse population of over 9.2 million. In 2019, NJ ranked 6th in cancer incidence rates nationwide with 483.7 cases per 100,000 (54,271 cases). CINJ is the State of New Jersey's only National Cancer Institute (NCI)- designated Comprehensive Cancer Center. The mission of CINJ is to reduce the burden of cancer by advancing cancer research, prevention, screening and education for the most densely-populated and one of the most ethnically and socioeconomically diverse states in the US.